Characterizing TDP-43 related hippocampal degeneration and memory loss in aging

PROJECT SUMMARY/ABSTRACT
TDP has emerged as an important and common age-related pathology related to the Alzheimer’s clinical
syndrome. TDP pathology is found in large number of older brains and is strongly and independently related to
episodic memory impairment. TDP pathology occurs in “normal aging,” with and without concomitant
Alzheimer’s disease (AD) pathology, and as a primary component hippocampal sclerosis (HS). The clinical
syndrome associated with TDP pathology mimics and worsens the Alzheimer’s clinical syndrome. TDP (with
and without HS) pathology commonly occurs with AD as mixed pathology and lowers the threshold for
dementia (lowers resilience). TDP also occurs in the absence of a pathologic diagnosis of AD and therein is
separately associated with memory loss and a dementia that mimics AD. Emerging data suggest that TDP
pathology has a large public health impact. Yet, there remain many gaps in our knowledge regarding TDP and
related neurodegeneration and cognitive impairment. To advance the field requires better defining the TDP
pathology of aging syndrome with currently available tools. The hippocampus is vulnerable in most age-related
dementias, but little is known about the specific role for TDP pathology in hippocampal degeneration and
memory loss in aging. The goal of this proposal is to elucidate the morphologic and neurobehavioral
phenotype of TDP pathology. The hypothesis is that TDP has a unique profile of hippocampal degeneration
and associated cognitive and behavioral deficits that can be separated from AD and vascular pathologies. We
capitalize on a rich large resource of older persons from well characterized and longitudinally followed older
community dwelling subjects enrolled without dementia with high follow-up and autopsy rates. In the first aim
we investigate brains to study the association of TDP pathology with neurons, astrocyte and microglial
densities in multiple regions of hippocampus; and perform a broader search for HS which is patchy and under-
recognized. In the second aim we use ex-vivo MRI imaging to link hippocampal size and shape to TDP after
controlling for AD and vascular pathologies. In the third aim we create a hippocampal shape/size imaging
score for TDP and translate this score from ex-vivo to in-vivo and pathologically validate the marker in those
with in-vivo scans that die and come to autopsy. In the fourth aim we investigate the early neurobehavioral and
cognitive characteristics of TDP pathology. Finally, in aim 5a we investigate the mechanism by which TDP is
associated with memory decline using the new data on neurons, glia, and HS. In 5b we investigate whether the
in-vivo TDP imaging score is associated with memory decline and incident Alzheimer’s type dementia. These
studies on TDP pathology in aging will advance the field and have a strong potential to enhance and our
understanding and the diagnosis of TDP in the spectrum of Alzheimer’s type clinical syndrome.

Public health relevance
PROJECT NARRATIVE TDP is a common age-related pathology that is related to episodic memory loss and the Alzheimer’s clinical syndrome. It is pivotal to understand the morphologic and neurobehavioral phenotypes of TDP and whether it is modified by other pathologies - to guide studies of prevention and treatment.